IDENTIFYING SALT-SENSITIVE HYPERTENSION

The purpose of this study is to determine the importance of salt intake in causing, or contributing to, high blood pressure. The most active subproject of this study examines postpartum women with or w/o high blood pressure during pregnancy to see if differences in salt sensitivity between the groups is an indicator and/or cause for the development of hypertension during pregnancy.